Global Hypomethylation Biomarkers for Cervical Cancer Screening in Women Living with HIV in LMICs

Project Summary
Cervicalcancer (CC) is one of the most common cancers in low and middle-income countries (LMICs).
This situation is worsened by a high prevalence of human immunodeficiency virus (HIV) infection in
certain African countries, such as Nigeria and Tanzania. Effective screening and early detection is the
key to preventing CC. However, multiple Pap smear visits for screening test remains costly in LMICs and
coverage of CC preventive strategy reach fewer women at risk of CC in LMICs, in particular HIV-infected
women. An alternative easy, affordable, non-invasive CC front-line screening tool for HIV-associated CC
is urgently needed in LMICs with high HIV prevalence.
The molecular changes by which HIV infection promotes cervical carcinogenesis remain largely unknown.
Epigenetic aberrations, especially global DNA methylation (DNAm) loss in repetitive element (RE)
regions, have been recognized as a hallmark of human cancers. REs are DNA sequences that occur in
multiple copies throughout the genome. If REs are activated (for example, by HIV infection) they can
multiply and reinsert themselves into human DNA at new genomic locations, leading to genomic instability
and somatic mutations that may cause cancer. DNAm in these REs is a protective mechanism to stabilize
RE from translocation, and its loss has been observed seen in the early phase of tumorigenesis.
Specifically, HIV infection has been shown to reduce global DNAm level and reactivate RE translocation
activity. We thus hypothesize that HIV infection may promote CC development via causing global
demethylation of RE and that such epigenetic changes in self-collected cervical intraepithelial neoplasia
(CIN) samples may predict progression into invasive CC.
We propose two study aims. In Aim 1, we will identify and validate HIV-associated CC global RE DNAm
biomarkers. We will utilize the existing DNAm data from our ongoing U54 CC epigenomic project in
Nigeria (U54CA221205, PI: Hou/Murphy) to generate global RE DNAm data for biomarker development
using our novel bioinformatics methods. We will then validate the biomarkers by implementing an
affordable, targeted, and quantitative PCR-based DNAm platform in a LMIC laboratory. In Aim 2, using
the same PCR-based approach, we will test if the biomarkers validated in Aim 1 can predict risk of CC
progression. We will leverage two groups of samples from longitudinal cohorts of HIV-positive women
who had low-grade CIN: a) Nigeria Pap smear samples from our U54 cohort; and b) Tanzania
cervicovaginal swab samples from an independent U54 cohort (U54CA190155, PI: Wood/Soliman).
Testing our biomarkers in self-collectable cervicovaginal swabs in our Tanzania cohort allows us to test
their feasibility and clinical relevance in LMIC settings. If successful, our study may help develop new
possible future CC screening and early detection tools for women living with HIV in LMICs.

Public health relevance
Project Narrative This study aims to study novel global DNA methylation aberrations, a hallmark of cancer, in cervical cancer women with HIV infection in two African countries, i.e., Nigeria in West Africa and Tanzania in East Africa. Our results will not only provide new mechanistic insight into HIV-associated cervical cancer, our unique study population and study design will also allow up to test the feasibility and clinical utility of the identified biomarkers as a first-line screening tool for HIV-infected women and in conjunction with Pap smear practice. Our study will promote the development of economic and effective cervical cancer screening tools for early detection and treatment of cervical precancerous abnormalities among HIV- infected women in low- and middle-income countries.